Probing the Nexus: Unraveling Neuroinflammation's Link to Anhedonia

Project Summary / Abstract
Anhedonia, a multifaceted construct encompassing reduced pleasure, decreased motivation, and
impaired reward learning 1, represents a clinically relevant symptom dimension observed across diverse
psychiatric disorders 2–13. Linked to poor therapeutic responses, anhedonia imposes significant economic and
care burdens 14–16.
Recent studies highlight inflammation's pivotal role in anhedonia's pathophysiology, with a primary focus
on peripheral inflammation 17. However, only a limited number of PET studies delve into neuroinflammation in
the central nervous system 17–20, and even fewer explore longitudinal associations 21–23, leaving critical gaps in
our understanding of how inflammation precisely influences anhedonia.
This R03 proposal addresses these gaps by utilizing the UK Biobank and Adolescent Brain Cognitive
Development datasets, along with the innovative diffusion basis spectrum imaging technique. Our central
hypothesis posits that neuroinflammation mediates the association between peripheral inflammation and
anhedonia symptoms, with an examination of potential age-related effects on this mediation relationship. Building
on existing evidence 17,24,25, this project focuses on reward processing brain regions, and investigates cross-
sectional and longitudinal relationships between peripheral inflammation, regional neuroinflammation, and
anhedonia symptoms.
By examining neuroinflammation's role in anhedonia, this secondary analysis project aims to provide
novel insights into the dimensional symptom's etiology across mental disorders and highlight potential age-
specific patterns. Future studies could extend to patient cohorts, exploring anhedonia in diverse disorders with
additional measures for brain structure and function in the reward circuitry, as well as modifiable environmental
and psychosocial factors. These future investigations hold the potential to validate the clinical relevance of the
neural and inflammatory phenotypes trans-diagnostically and may ultimately inform interventions and treatments.

Public health relevance
Project Narra+ve Evidence suggesting a vital role of inflammation in anhedonia has predominantly focused on peripheral inflammation markers or stems from small-scale PET imaging studies, leaving critical gaps in our understanding of neuroinflammation’s contribution to anhedonia. This R03 project will leverage two large-scale datasets, along with an innovative imaging technique, to test the hypothesis that neuroinflammation mediates the association between peripheral inflammation and anhedonia symptoms. The findings of this study will provide novel insights into the pathophysiology of anhedonia and inform future research investigating the relevant neural and inflammatory phenotypes trans-diagnostically.